Pro-inflammatory activation of human macrophages regulated by lncRNAs

Project Summary
Macrophage activation promotes major inflammatory disorders, including arterial diseases. Its underlying
mechanisms, however, remain obscure. The present study will establish a systems approach, involving
computational prediction analyses, multi-omics, network science, and in vitro and in vivo validation, to
discover long noncoding RNA (lncRNA)-mediated mechanisms for pro-inflammatory activation of
macrophages and arterial disease. In Specific Aim 1, we will involve omics studies of human macrophages
to identify lncRNAs and their interacting proteins and develop computational analyses to predict human
lncRNAs that regulate macrophage activation. Specific Aim 2 will examine the functionality of candidate
lncRNAs in macrophage activation in vitro and in vivo. The findings from the study will help to identify new
mechanisms for macrophage activation and may provide molecular bases for new therapies.

Public health relevance
Project Narrative Inflammation plays a key role in coronary artery disease and other major vascular diseases, global health threats. Even with potent risk modifiers, e.g., statins, many patients still suffer vascular events. Long noncoding RNAs (lncRNAs) regulate various biological processes. We aim to discover lncRNAs that promotes vascular inflammation. The potential outcomes will offer new targets for much needed therapies for vascular diseases.